Data Analysis Center for Somatic Mosaicism Across Human Tissues Network

PROJECT SUMMARY
The goal of the Somatic Mosaicism across Human Tissues (SMaHT) Network is to better characterize the occurrence
of mosaic variants in human tissues and to understand their role in the regulation of biological processes that
impact health and disease. The SMaHT Data Analysis Center (DAC) aims to collect and curate all data generated
in the Network; assess, develop, and apply state-of-the-art analytical pipelines; and produce a variant catalog and
a data portal for the scientiﬁc community. We have assembled a team of investigators, bioinformatics scientists,
data curators, and software developers with a strong track record in mosaic variant analysis, long-read data
analysis, data portal development, visualization, large-scale data management and computing, and development
of secure and ﬂexible cloud technologies. In Aim 1, we will work with the Network members to deﬁne data and
metadata standards and ensure that high-quality data are generated, processed, and annotated uniformly and
efﬁciently. In Aim 2, we will perform benchmark studies for the current tools and technologies for identiﬁcation
of mosaic variants and lead an effort to deﬁne and implement analytical pipelines on a cloud platform. We will
also develop new approaches as needed. We will ensure that a comprehensive set of mosaic variants of all types
(single nucleotide variants, indels, copy number variants, translocations, complex rearrangements, transposable
element insertions, microsatellite mutations, repeat expansions, etc.) are identiﬁed, using short- and long-read
platforms, genome-wide and targeted assays, and bulk and single cell technologies. In Aim 3, we will build a
user-friendly and interactive data portal containing a variant catalog and featuring a read-level variant browser to
enable the scientiﬁc community to fully utilize the Network data. We will ensure that all methods and processes
are documented for full reproducibility and that all tools and data are freely available to the community.
1

Public health relevance
PROJECT NARRATIVE Characterization of somatic variation in human tissues is fundamental to our understanding of disease processes. We will develop a platform for data collection, curation, analysis, and visualization for the Somatic Mosaicism across Human Tissues (SMaHT) Network. The variant catalog, workbench, and data portal we develop will enable the scientiﬁc community to take advantage of the data, tools, and technologies developed by the Network. 2